The Mid-Atlantic Center for Cardiometabolic Health Equity (MACCHE)

OVERALL
PROJECT SUMMARY
The overarching goal of the Mid-Atlantic Center for Cardiometabolic Health Equity (MACCHE) is to test the
effectiveness of comprehensive, integrated, and multi-level evidence-based strategies for improving
cardiometabolic health outcomes among socially disadvantaged populations in Maryland. The MACCHE will
include 5 separate, but related research projects addressing disparities in cardiometabolic disease; 3
integrated cores (Administrative, Investigator Development, and Community Engagement); an Executive
Committee; and a Community Advisory Board. The first 3 projects are currently underway and include: Project
1 (Healthy for Two), a randomized trial comparing the effectiveness of an evidence-based
pregnancy/postpartum health coaching/home visiting intervention to usual home visiting services in reducing
postpartum weight retention among Black and Latinx birthing people at high risk for cardiometabolic health
disparities; Project 2 (UNLOAD-Heart Failure) is a randomized trial examining the effectiveness of a multi-level
intervention of problem-solving training, community health worker (CHW) support and partnership with
community facilities for enhancing cardiorespiratory fitness in adults with low socioeconomic status, diabetes,
obesity and asymptomatic cardiac dysfunction; and Project 3 (LINKED-HEARTS) is a cluster-randomized trial
testing the effectiveness of a multi-level intervention linking self-monitored blood pressure (BP) with
telemonitoring, team-based care with pharmacists and CHWs, and provider-level interventions compared to
enhanced usual care, for improving BP control among socially disadvantaged adults with uncontrolled
hypertension plus diabetes or chronic kidney disease. The 2 additional proposed studies include: Healthy for
Two-Hearts which builds upon Healthy For Two, to address racial and ethnic disparities in hypertension in
postpartum birthing people, with an emphasis on two effective strategies for blood pressure reduction: low
salt/high fruit and vegetable diet (including food delivery) and stress management; and DASH-Life which will
pilot a Food-is-Medicine intervention for adults with hypertension and type 2 diabetes residing in Healthy Food
Priority Areas in Baltimore (`food deserts')—a population at high risk for adverse cardiometabolic health
outcomes. The MACCHE will advance the science of cardiometabolic disease disparities and facilitate its
translation into clinical and public health practice and policy.

Public health relevance
OVERALL PROJECT NARRATIVE The overarching goal of the Mid-Atlantic Center for Cardiometabolic Health Equity (MACCHE) is to test the effectiveness of comprehensive, integrated, and multi-level evidence-based strategies for improving cardiometabolic health outcomes among socially disadvantaged populations in Maryland, USA. The MACCHE will advance the science of cardiometabolic disease disparities and facilitate its translation into clinical and public health practice and policy.